CORE--ZEBRAFISH GENETICS AND AQUARIUM

Genetics Facility: The primary objectives of the Genetics Facility are: 1) ENU mutagenesis; 2) providing mutagenized stocks for screens described separately in each of our Component Projects, and 3) providing pathenogenetic offspring, both androgenetic and gynogenetic, for mutation screens. Aquarium Facility: The objectives of the zebrafish Aquarium Facility are to provide: 1) husbandry of fish stocks; 2) quarantine facilities for newly acquired stocks; 3) staged eggs; 4) procedure rooms and equipment for microinjection of eggs; 5) a liquid nitrogen (LN) freezer for storing frozen sperm; 6) databases on the facility's fish stock collections; and 7) advice and training on fish husbandry and facility set-up.